NCI Early Career Cancer Clinical Investigator Award

Project Summary/Abstract
With support from the NCI Early Career Investigator Award, Dr. Rifaquat Rahman aims to focus on the
development of clinical trials while exploring the use of novel clinical trial designs to identify therapies
that can improve the outcomes of patients with adult gliomas. Specifically, this will include the continued
development of a large cooperative group phase 3 trial evaluating the use of IDH inhibitors for IDH-
mutant anaplastic astrocytomas, as well as several ongoing trials evaluating novel treatment approaches
for glioblastoma. Furthermore, he will lead a national initiative to develop data-sharing mechanisms in the
field of neuro-oncology. This initiative will also facilitate collaboration to develop, explore and validate
the use of novel clinical trial designs that can increase the efficiency of the clinical trials in glioblastoma
and accelerate drug development such as the use of adaptive platform trials and external control arms.
This national initiative, along with Dr. Rahman’s ongoing validation research of these novel trial designs,
has potential to improve the conduct of clinical trials, to enable data sharing in the field of neuro-
oncology and to serve as a model for other disease sites in oncology. Dr. Rahman will continue efforts for
collaborative, scientifically rigorous and cutting-edge clinical trial program for adult IDH-mutant and
IDH-wildtype gliomas with the support of the Dana-Farber/Harvard Cancer Center. He will also become
more involved in cancer center activities, attend relevant conferences and expand his roles within the NCI
clinical trial network. As part of his career development as a leading clinical investigator, Dr. Rahman will
continue to be dedicated to the mentorship of medical students, residents and fellows. In summary, Dr.
Rahman will greatly benefit from the support of the NCI Early Career Investigator Award in his career
goals to succeed as a cancer investigator with a focus on clinical trials and therapeutic development for
adult gliomas.

Public health relevance
Project Narrative With support from the NCI Early Career Investigator Award, Dr. Rifaquat Rahman will work to develop clinical trials for adult primary brain tumors with an emphasis on novel clinical trial designs to help create trials that can be completed faster and more efficiently. Dr. Rahman strives to develop clinical trials that are conducted with novel methods that make them more efficient so that there can be faster and more precise identification of new therapies that can improve the outcomes of brain tumor patients. In addition to his work developing multiple clinical trials that are evaluating promising therapies for primary brain tumors, he will lead a nationwide initiative with relevant parties to develop, validate and execute novel clinical trial designs to accelerate drug development for primary brain tumors.